South Dakota Tribal PRAMS

ABSTRACT Tcohlela2b0o1ra6tSivoeuethffoDratkboettawTereibnatlhPerNegonrtahnecrynRPilsakinAssTersibsmaleEnptiMdeomniotolorignygCSeynsterm(N(SPDTETC- )P,RthAeMGSr)eiasta PanladinthseTrNiobratlhCDhaikromtaena?nsdHSeoaulthBDoakrodta(GDPeTpCaHrtBm)eMnCtsHoDfHepearlthm.eTnht,etShDeETA-PMRAarMtiSnpPropgorasems/aSPDoSiUnt,- ion-eTiomf (e4()CroemseprovnaetinotnBc)osmurmvuenililatinecse: TphreojLeackt ecoTnrdauvcetresde aRmesoenrgvaAtmioenraicnadnSItnadnidainwg Romocekn living in rwehsiecrhvatrieonlosc,awtehdicshosleplaynwNitohritnhSaonudthSoDuatkhoDtakbotrad,earnsd. tShDeTC-rPoRwACMrSeeskeravnedsFthlaenderedauofreservations, GbyPTpCroHvBid/iNnPgTcEuCrr?senptaratnicdipuasteifnugl pTarirbtnael-rleTvreilbMesCaHs dwaetlal taos gthuoidse poof ltihceyiranSdtaitnefoanrmd Fperdoegralmpmarattniecrs achctiildvihtieasldthesoiugtnceodmteosi.mprove women’s health, reduce disparities, and foster positive maternal and

Public health relevance
Project Narrative The 2016 South Dakota Tribal Pregnancy Risk Assessment Monitoring System (SD T- PRAMS) is a collaborative effort between the Northern Plains Tribal Epidemiology Center (NPTEC), the Great Plains Tribal Chairmen’s Health Board (GPTCHB) MCH Department, the EA Martin Program/ SDSU, and the North Dakota and South Dakota Departments of Health. The SD T-PRAMS proposes a Point-in-Time (Component B) surveillance project conducted among American Indian women living in one of (4) reservation communities.